Supporting Vaginal Birth in Illinois: the Role of Unit Culture

SUMMARY
Cesarean deliveries (cesareans), when used judiciously, save lives. However, research indicates that the use
of cesareans in the United States (US) has risen well above the level of necessity and has become a
contributor to maternal morbidity and mortality. Patients who have cesareans face increased risk of serious
complications such as amniotic fluid embolism, catastrophic hemorrhage, placental abnormalities in future
pregnancies, and death. Babies born by cesarean face increased risk of respiratory complications, and,
emerging research suggests, chronic disease. For these reasons, the Healthy People 2020 goal is to reduce
cesarean rates to ≤ 23.9% for first-time mothers. Currently, over one-third of all women giving birth in the
United States deliver via cesarean. Hospital cesarean rates across the US range from 6% to 69%, and
significant variation remains even when controlling for patient clinical factors and hospital and patient
demographics. Patient request for a cesarean make up less than 1% of cesareans nationwide, and, thus,
cannot explain this variation. Our prior work has found that this variation in practice is associated with labor
and delivery unit culture and, moreover, that successful reduction in cesarean overuse correlates with specific
aspects of unit culture, such as decreased fear of vaginal birth, physician acceptance of oversight, agreement
with evidence-based practices, and belief in the importance of maternal agency. Organizational culture has
been shown to be a key element in reducing variation in hospital outcomes in other clinical areas; and,
underscoring its importance, the national safety bundle addressing cesarean overuse charges hospitals to
“develop a unit culture that supports vaginal birth.” Unfortunately, there is evidence that this aspect of quality
improvement receives the least attention from hospitals that participate in initiatives to reduce cesarean
overuse. After 2 years of a California statewide initiative, about 42% of hospitals still had cesarean rates over
the Healthy People 2020 goal. This is not surprising given that few tools and no rigorously designed user-
centered tools exist to help hospitals implement culture change. This proposal leverages the strength and
support of multiple state-level perinatal quality collaboratives at different stages of implementation and a novel,
continually improving Labor Culture Survey tool. We will engage in a comprehensive user-centered design
process to create, adapt, and implement a “Culture Change Toolset” for use in hospital-based, organizational
culture quality improvement efforts to reduce cesarean overuse. Furthermore, we will incorporate patient
perspectives and feedback as key stakeholders in the design and adaptation process. Based on our prior data,
a 1-point improvement in unit culture supportive of vaginal birth would convert 331,773 cesarean deliveries or
27% of US cesarean births and 9% of all US births each year to vaginal deliveries and the low-risk, primary
cesarean rate would decrease from 28% to 19%, thus achieving the Healthy People 2020 goal and improving
maternal and newborn morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Cesarean delivery, when overused, is harmful to women and newborns, and raises healthcare costs without appreciable benefit; yet, despite significant efforts to reduce overuse, persistent and scalable improvement has been elusive. Organizational culture change strategies have been successful in improving outcomes in other areas of healthcare, but tend to receive little attention in statewide cesarean reduction initiatives as evidence- based tools to facilitate change are lacking. This proposal seeks to use rigorous user-centered design and implementation science principles to develop a “Culture Change Toolset” to target the most upstream causes of L&D units’ failure to adopt and sustain change in cesarean delivery rates.